Detection of Emergent Mechanical Properties of Biologically Complex Cellular States

Project Summary
Although aging, germline mutations, and family history of cancer are significant risks for breast cancer, it is still
unclear why one person’s breast cells are more susceptible to this disease than another person’s. Aging changes
cells and tissues such that they become more susceptible to cancer initiation. Our published data show that
breast epithelial cells from young women who have high-risk germline mutations show accelerated aging with
intermediate filament distribution, biological clock acceleration, and stromal immune cell milieu changes
comparable to those of women who are 20–40 years older. In our currently funded R01EB024989, we discovered
that the mechanical properties of normal breast epithelial cells, as measured by our mechano-Node Pore
Sensing (mechano-NPS) platform, differ among younger and older women and that normal epithelial cells from
genetically high-risk women who carry germline BRCA1, BRCA2, or PALB2 variants are mechanically “older”
than their chronological age. We hypothesized that mechano-NPS can detect disease states based on the
emergent mechanical properties that arise from the underlying molecular networks that define lineage and
disease states. In this competitive renewal application, we extend this hypothesis to include detection of cancer
susceptibility or risk, which is so far not detectable with genetic screening. We will innovate mechano-NPS and
advance an in silico model of our device to increase the number of physical parameters it can measure, thereby
providing a more complete portrait of single human mammary epithelial cells (HMECS) (Aim 1). We will build a
machine learning cancer susceptibility detection system based on measuring mechanical properties of different
primary HMEC (young, old, high-risk, family history of breast cancer, etc.) (Aim 2). Finally, we will dissect the
molecular mechanisms of mechanical states measured by our advanced mechano-NPS platform (Aim 3). In the
last funding period, we successfully designed, built, and validated the first-generation mechano-NPS platform at
UC Berkeley and showed it to be portable and robust by building a second platform at City of Hope. The impact
of our competitive renewal application will be far more reaching. Clinically useful genetic testing relies on a
handful of known monogenic risk traits, but we hypothesize that emergent mechanical properties, measured
from just a few hundred cells, are a characteristic of the biology that underlies cancer susceptible states, even
those that are polygenic or epigenetic in nature and are passed within a family but that so far have defied
definition.

Public health relevance
Narrative Despite knowledge that age, germline mutations (e.g. BRCA1, BRCA2, or PALB2), and family history of cancer are all risk factors for breast cancer, understanding what makes one person more susceptible to this disease compared to another is not well known. We propose to leverage two remarkable discoveries we have made with our innovative microfluidic platform, mechano-Node-Pore Sensing (mechano-NPS) —breast epithelial cells from younger and older women have different mechanical properties, and cells from young women who are at very high risk of cancer because they carry a germline mutation appeared mechanically “older” than the women’s chronological ages—to develop a breast cancer susceptibility detection system, which will measure the “mechanical age” of a woman’s cells. Clinically useful genetic testing relies on a handful of known monogenic risk traits, but we hypothesize that emergent mechanical properties, measured from a few hundred cells, are a characteristic of the biology that underlies cancer susceptible states, even those that are polygenic or epigenetic in nature and are passed within a family but that have so far defied definition.